Role of P2Y Receptors and Activated Platelets in Inflammation

DESCRIPTION (provided by applicant): Analia Garcia, D.M.D. is an assistant professor at the Temple University Medical School. After her postdoctoral training in the molecular mechanisms of neutrophil and platelet activation, she was recently advanced to a faculty status. As an underrepresented minority, this award mechanism, Mentored Career Development Award to Promote Faculty Diversity in Biomedical Research, would help Dr. Garcia advance her academic research career by providing mentoring, facilities, and resources. Intellectual resources at Temple University faculty, including her mentor, Satya P. Kunapuli, Ph.D and co-mentor, Raul De La Cadena, M.D., and her advisory committee, working in the fields of inflammation, arthritis, and thrombosis are a great asset for her growth. Her research project is at the cross roads of inflammation and thrombosis, as it is becoming increasingly clear that inflammation and thrombosis are closely related processes and that activated platelets might be important in the regulation of inflammation. Clopidogrel (trade name Plavix), antagonizing P2Y12 receptors on platelets, is a widely used potent anti-thrombotic agent. Clopidogrel also inhibits the release of several chemokines and nucleotides from platelet granules that activate leukocytes. However, the effect of Clopidogrel or the platelet P2Y12 receptor blockade on inflammation has not been thoroughly evaluated. In the literature there are at least three clinical cases, including a recent double blind study, where Clopidogrel treatment aggravated inflammation. We hypothesize that "activated platelets regulate lymphocyte function thereby influence the inflammatory responses". The overall goal of this proposal is to "Evaluate the role of platelet P2Y receptor subtypes and activated platelets in animal models of inflammatory diseases". Our preliminary results show that Clopidogrel treatment, that dampens platelet activation, aggravates the inflammatory responses in a PG-APS -induced arthritis in a rat model. We will use several animal models of arthritis and inflammation to evaluate the effect of Clopidogrel and prasugrel, to test the hypothesis that Clopidogrel treatment increases inflammatory responses. As the platelet P2Y12 receptor is the known target of Clopidogrel, we will test the hypothesis that the P2Y12 receptor blockade reduces inflammatory responses but Clopidogrel treatment enhances inflammatory responses through non-selective action on other bloods cells, using multiple complementary approaches including in vivo use of Cangalore, a reversible antagonist of the P2Y12 receptor and the P2Y12 null mice. We will also evaluate the function of the leukocytes to test the hypothesis that Clopidogrel, prasugrel, or the corresponding active metabolitse affect the leukocyte function. These studies will also be performed with human leukocytes using the active metabolite of Clopidogrel or prasugrel. Further, they will also help us understand the role of P2Y12 receptors in inflammation and contribute to better treatments and to design therapeutics for inflammatory diseases.